Adminstrative Core

Core A. Administrative Core. The Administrative Core will serve to coordinate and support the activities of the Center in its entirety by facilitating communication between the PI, projects, cores, intemal advisors, external advisors, other Udall Centers, and the public. Salary support is requested for two individuals: The Center PI, Dr. Timothy Collier, and the Administrative Coordinator, Ms Michelle Gartland. Dr. Collier's effort will be devoted to oversight of the Core's activities, and participation in decision-making related to mechanisms for tracking progress and fiiture directions of the Center's scientific activities. This includesfrequentmeetings with Project Leaders and staff, annual meetings with intemal advisors and representatives of existing Udall Centers, bi-annual meetings with external advisors, and semi-annual revision of website content to communicate Center activities to the public. Day-to-day management of administrative activities (the real work) will be carried out by Ms. Michelle Gartland. Ms. Gartland has worked as an administrative/research assistant with Drs. Collier and Sortwell for five years. Her familiarity with both types of activities provides a significant advantage in execution of this role for the Center. In summary, the primary flmction of Core A is to enable communication. This will be achieved by 1) providing administrative support for the projects and cores, 2) scheduling and providing support for meetings between Center project leaders and intemal and external advisors, 3) facilitating travel and communication of data at annual Udall Centers meetings and meetings of national and international scientific societies, and 4) creating and maintaining a Center website. Ms. Gartland is experienced and talented in design of power point presentations and websites. These skills will enable center investigators to effectively communicate progress both to colleagues and to the public. The Center website will be the centerpiece of our group commitment to transparency in the use of Center funds as they apply to health and well-being of individuals with Parkinson's disease. RELEVANCE (See instructions): Core A provides the administrative structure to promote the educational and informational mission of Udall Center activities for patients with Parkinson's disease and the Cincinnati community at large.